Administrative Core

Project Summary The development and formation of normal and abnormal vasculature is of critical importance to both normal biology and disease pathogenesis. The Aim of this PPG is to determine key molecular mechanisms regulating arteriogenesis and discovery new therapeutic modalities that would help treat atherosclerotic cardiovascular disease. The purpose of Core A is to facilitate these efforts by providing administrative services to the PPG.